Unlocking Corneal Endothelial Regeneration: Novel Therapeutic Strategies for Fuchs' Endothelial Corneal Dystrophy

PROJECT SUMMARY
Fuchs' endothelial corneal dystrophy (FECD) is a degenerative ocular disease affecting 4% of people over 40
and more that >300 million people globally. A hallmark of FECD is the accelerated loss of corneal endothelial
cells (CECs), which are required for maintaining corneal transparency and visual clarity. This study will
elucidate the underexplored regenerative potential of the corneal endothelium and use this knowledge to
devise innovative therapeutic interventions for FECD. Our hypothesis, grounded in preliminary experiments, is
that CECs, although naturally dormant, harbor an innate capacity for regeneration. Using innovative live
imaging approaches, genetic mouse models, and modified mRNA technology to manipulate CECs in vivo, we
identified a prospective therapeutic pathway: stimulating CEC proliferation in vivo to renew the corneal
endothelium, thus restoring corneal transparency and vision in FECD patients. To test this, we propose a two-
pronged approach utilizing relevant animal models. Aim 1 centers on elucidating the proliferative potential of
CECs in normal physiology and during FECD progression. Using established mouse models that recapitulate
the main features of FECD, we will perform real-time analysis of CEC dynamics by two-photon microscopy.
Moreover, we will investigate the molecular blueprint of a pro-regenerative endothelial cell identity, that can be
targeted for therapeutic intervention in FECD. For this we will perform in vivo assays of precision corneal
endothelial ablation combined with single-cell genomic analyses to elucidate the molecular programs that
influence the proliferation of CECs in vivo. To further illuminate the signaling pathways responsible for
regulating the cell cycle of CECs in response to changes of their biomechanical environment during FECD
disease progression, we will test the requirement of YAP, the downstream effector of the Hippo pathway, for
corneal endothelial function and regenerative ability. Aim 2 builds on our preliminary data demonstrating
effective control of CECs with injectable mRNA-encoded growth factors to induce their proliferation in vivo. We
propose a new mRNA-based therapy for FECD by directly targeting CECs to prompt the regeneration of a
diseased corneal endothelium, restoring its functionality. Toward this, we will systematically test the optimal
composition and delivery of our mRNA therapeutic factors to develop a robust treatment protocol. We will
comprehensively evaluate the effectiveness and safety of our mRNA treatment in two complementary mouse
models of early- and late-onset FECD, then scale up to pre-clinical trials in canine and non-human primate
models. Our team of investigators with deep expertise in regenerative biology and FECD disease modeling is
optimally equipped to carry out this research. With this study, we are aiming to not only revolutionize our
understanding of corneal endothelial physiology and FECD pathophysiology, but also develop groundbreaking
mRNA-based treatments to bring restored sight for patients with FECD and possibly other ocular degenerative
diseases closer to reality.

Public health relevance
NARRATIVE This to endothelial research Medicine understanding project implements innovative live imaging approaches, cutting-edge genetic tools, and mRNA technology investigate the regenerative potential of the corneal endothelium and to test a novel therapy for Fuchs' corneal dystrophy (FECD) using relevant animal models. The overal l goals and scope of this aligns with the mission of the of National Eye Institute and its Strategic Plan for Regenerative approaches to treat ocular disease. Knowledge generated from this study will be essential for and treating FECD and other ocular degenerative diseases.